Yale TMC for Cellular Senescence in Lymphoid Organs

PROJECT SUMMARY
Cell senescence in human tissues is an irreversible cell cycle arrest state in otherwise proliferative cells, which
is a hallmark of aging that alters the tissue environments via senescence-associated secretory phenotype
(SASP) but may also play a beneficial role in tissue remodeling, regeneration, and wound healing. Lymphoid
organs play a vital role in hematopoiesis and immune function. How cellular senescence in these tissues is
associated with stress-induced or age-related functional impairment, what types or subtypes of senescent cells
are present and their spatial heterogeneity and how these cells impact the tissue environments remain poorly
understood, precluding the development of strategies to target senescent cells to improve healthspan/lifespan
or harnessing these cells or secreted factors to promote tissue remodeling and repair. A recent commentary
published in Cell by NIH identified five broad areas (atlases, imaging &visualization, biomarkers, model
systems, perturbation and validation) that would help propel the field forward. Our application will assemble a
multidisciplinary team to tackle all these areas and specifically, as a Tissue Mapping Center (TMC), will focus
on generating the molecular and cellular maps of cellular senescence and associated tissue environments in 4
primary and secondary lymphoid organs. Specifically, it will (a) collect, analyze, annotate, and share high
quality non-diseased human primary (bone marrow and thymus) and secondary (tonsil and lymph node)
lymphoid tissues, (2) develop and deploy a suite of high-resolution, high-content and high-throughput single-
cell & spatial omics technologies to characterize these specimens and paired biofluids, and (3) perform
integrated informatics to identify biomarkers of senescent cell heterogeneity and to construct comprehensive
molecular and cellular maps of cellular senescence and associated environments in these organs. Four major
biological analysis pipelines are: (1) single-cell high-plex (>40) protein secretome profiling, (2) single-cell
proteo-transcriptomic sequencing (scCITE-seq), (3) spatial proteo-transcriptomic sequencing at cellular level
(DBiT-seq for co-mapping whole transcriptome and a panel of ~300 proteins at cellular level with 10µm pixel
size), and (4) spatial molecular imaging (SMI) of ~1,000 molecular targets in FFPE tissues at single-molecule
subcellular resolution. With these unique tools, we will (a) characterize functional SASP heterogeneity and
identify biomarkers of SAPS in different cell types, (b) construct molecular and cellular maps in 4 human
lymphoid tissues, and (c) identify biomarkers of cellular senescence in tissue and the associated environments,
contributing to the resource building of SenNet. Since the immune function is central to the physiology of all
major organs, our study will provide insights to the role of senescent immune cells in development, aging, or
disease in other organs like gut, lung, liver, and kidney, representing a strong synergy within SenNet and the
wider scientific community.

Public health relevance
PROJECT NARRATIVE This project aims to use high-throughput and high-resolution single-cell and spatial omics technologies to characterize senescent cell heterogeneity and environments. It will generate multiscale molecular and cellular maps of cellular senescence in primary and secondary human lymphoid organs, representing a highly valuable data resource to improve our understanding of cellular senescence in development, aging, and disease.